J-RISE: Relevant Implementation Strategies to Enhance access to care and employment among individuals who have been impacted by the criminal legal system

Individuals impacted by the criminal legal system experience delays in accessing care and securing and maintaining gainful employment. Status neutral interventions are pertinent and urgently needed to support care and employment for this population. Our collaborative has prioritized three status neutral interventions (i.e., transitional case management [TCM], employment navigation [EN], and contingency management intervention [CMI]). Combining these interventions together will maximize their independent effectiveness and provide significant promise for improving health and employment outcomes. We will utilize seven prioritized bundled implementation strategies to support the adoption, implementation, and sustainability of these status neutral interventions within community and correctional settings. The overarching goals of the planned multi-site type 2 hybrid effectiveness-implementation study, J-RISE: Relevant Implementation Strategies to Enhance access to care and employment among individuals who have been impacted by the criminal legal system is to simultaneously evaluate the effectiveness and implementation of two packaged status neutral interventions within correctional and community settings. J-RISE is led by an academic, community, and correctional collaborative and conducted in three Ending the HIV Epidemic (EHE) jurisdictions in Illinois and Louisiana. Aim 1. Evaluate the effectiveness of two packaged status neutral interventions (TCM versus TCM+EN+CMI) on primary outcomes (linkages to HIV care, PrEP care, and employment-related services within 90 days) and secondary outcomes (receipt of mental health and substance use services, retention in HIV care, viral suppression, retention in PrEP care, and sustained employment). Aim 2. Evaluate the bundled implementation strategies and implementation outcomes at multiple levels using CFIR, RE-AIM, and MIPA. Key implementation outcomes include acceptability, adoption, costs, fidelity, penetration, and sustainability. J-RISE will generate novel information about the utility of our chosen implementation strategies as well as critical information about the effectiveness and cost of packaged status neutral interventions to optimize care and employment outcomes for individuals who have been impacted by the criminal legal system in multiple EHE jurisdictions.

Public health relevance
Project Narrative The proposed study will examine the implementation and impact of delivering two packaged status neutral interventions focused on enhancing access to HIV and employment-related services for justice-involved Black men who have sex with men in Illinois and Louisiana.